Advancing catheter electrochemical impedance spectroscopy for precision medicine of embolotherapy

Project Summary/Abstract:
Catheter embolization is a critical treatment for multiple diseases, including hepatocellular carcinoma,
uterine fibroids, renal cell carcinoma, and massive hemoptysis in cystic fibrosis. However, current embolization
endpoint assessment is subjective, relying on intermittent X-ray imaging to evaluate blood flow qualitatively in
the treated artery. Current X-ray embolization endpoint assessment methods are operator-dependent and not
quantitative, leading to potential undertreatment or overtreatment.
Our research aims to develop a novel method for quantitative flow assessment within the treated artery,
providing a more accurate evaluation of embolization treatment. I propose integrating electrochemical
impedance spectroscopy (EIS) sensors into catheters for real-time monitoring of embolization. Catheter sensing
of embolization will reduce reliance on high-radiation techniques like quantitative digital subtraction angiography
and avoid impracticalities associated with Doppler guidewires and intraoperative MRI flow assessment.
In this project, I will miniaturize sensor catheter technology to microcatheters, that are commonly used
for embolization and are able to track through small blood vessels. In addition, I will evaluate feasibility of new
methods for continuous blood flow determination by the sensor catheters. Upon completion, this project will
enhance the clinical translatability and utility of catheter embolization by realizing sensor microcatheters
potentially providing continuous blood flow sensing. This innovation will have broad applications in intravascular
flow sensing, benefiting fields such as interventional radiology and cardiology, ultimately improving the safety
and efficacy of catheter procedures.

Public health relevance
Project Narrative: This research aims to enhance public health by developing a novel method for quantitative flow assessment in catheter embolization treatments, applicable to diseases like hepatocellular carcinoma and uterine fibroids. By integrating electrochemical impedance spectroscopy sensors into microcatheters, we will provide real-time monitoring of embolization, reducing reliance on high-radiation techniques and improving treatment accuracy. This innovation will improve the safety and efficacy of catheter procedures in interventional radiology and cardiology, ultimately benefiting patients through more precise and effective treatments.